2022-2023 Tobacco Use Supplement to the Current Population Survey (TUS-CPS)

NCI will provide funds to the Census Bureau. Census will collect and analyze survey data, develop copies of survey instruments, make recommendations for sponsor cognitive testing, and create a timeline for fielding and data delivery of the project. Project is related to Tobacco Use Supplement. The Tobacco Use Supplement to the Current Population Survey is a National Cancer Institute sponsored survey of tobacco use that has been administered as part of the US Census Bureau's CPS approximately every 3-4 years since 1992-1993.